Site-randomized Trial of a Novel Social Network Recruitment Intervention to Locate More Undiagnosed Positive Cases of HIV, Increase HIV Testing among Men, and Reduce HIV-related Stigma in South Africa

PROJECT SUMMARY/ABSTRACT
In South Africa's large generalized HIV epidemic, male-to-female transmission comprises a large
proportion of transmission events, but men are much less likely to seek HIV testing, and disproportionately
remain undiagnosed. HIV-related stigma is a key barrier to recruiting men to HIV testing in South Africa, as
they report feeling blamed by their partners and communities for HIV transmission. This barrier must be
addressed to increase testing among men and other testing-avoidant people in order to locate “hard-to-reach”
undiagnosed cases and make progress towards 95-95-95 goals. Peer recruitment via social networks is an
effective mechanism for promoting HIV testing, because people seek health information from peers, and peers
influence health behavior norms within networks. However, standard risk network recruitment is limited in that:
1) recruiting one's own risk partners can trigger stigma and blame for HIV; and 2) it excludes people who have
not engaged in HIV risk behavior recently and/or who no longer have contact with their risk partners. We
developed an expanded social network recruitment to HIV testing (E-SNRHT) intervention to address
these limitations and reduce stigma as a barrier to testing. E-SNRHT asks newly diagnosed HIV+ (NDP)
“seeds” (i.e., initial participants) to recruit their expanded social network members (i.e., anyone they know) who
they think could benefit from HIV testing or could be HIV+ unaware, tests these network members, and refers
them to ART (if positive) or follow-up testing (if negative). By asking participants to recruit non-risk partners, E-
SNRHT is designed to increase their comfort and likelihood of recruiting others, especially those who have
avoided testing due to stigma. Our two pilot studies of E-SNRHT found that it recruits men to HIV testing at
much higher rates than standard risk network recruitment; locates previously undiagnosed cases (NDP) at a
much higher rate per seed than standard risk network recruitment; and recruits people who have not tested in
years, have never tested, and/or have not engaged in HIV risk behavior recently but are HIV positive-unaware.
We also found that E-SNRHT reduces HIV-related stigma and increases HIV-related social support among
networks; and that 76% of E-SNRHT NDP started ART within 10 weeks. As participants recruit each other,
their discussions help to normalize talking about HIV, thereby improving levels of stigma and support, which in
turn should increase HIV service use and improve HIV care cascade outcomes. We will conduct a site-
randomized trial of E-SNRHT, with 32 Department of Health clinics in KwaZulu-Natal, South Africa serving as
sites. We will compare E-SNRHT clinics to business-as-usual control clinics on: their rates of recruiting men to
testing (Aim 1a) and locating NDP (1b); participants' reports of HIV-related stigma and social support (Aim 2a);
and treatment cascade outcomes (2b). We will also use implementation science methods and qualitative
methods to develop best practices (Aim 3) for future scale-up in South Africa and adaptation to other settings.

Public health relevance
PROJECT NARRATIVE The proposed project will conduct a clinical trial that compares “business as usual” HIV testing in Department of Health clinics in South Africa to a novel intervention that aims to expand the reach of HIV testing and locate “hard-to-reach” undiagnosed cases of HIV by asking newly-diagnosed HIV-positive individuals to recruit their “expanded” social network members (i.e., friends and peers who are not necessarily direct risk partners) who they think might be at risk of being HIV-positive but undiagnosed to HIV testing, followed by referral to treatment or follow-up HIV testing services. The intervention's expanded social network recruitment will facilitate conversations between peers that will help to change norms around discussing HIV testing, increase HIV-related social support, and reduce HIV-related stigma among network members. These changes in stigma and support will in turn increase the likelihood that the members of these social networks will engage more in HIV testing and treatment services, ultimately leading to reduced HIV transmission and improved HIV health outcomes not only among individuals who had previously avoided engagement in testing and treatment, but also among the broader communities in which the intervention is implemented.